SUMOylation of Cu transport protein Atox1 in Atherosclerosis

The aim of this grant is to demonstrate a novel redox-dependent SUMOylation of Copper (Cu) chaperone
“Antioxidant-1 (Atox1)” as a key switch to promote Cu-dependent transcription factor function linked to
vascular inflammation and atherosclerosis. Cu is implicated in inflammation and atherosclerosis with
unknown mechanism. We previously found that Cu-chaperone Atox1 functions as a Cu-dependent transcription
factor for p47phox to promote reactive oxygen species (ROS)-dependent inflammatory responses in inflamed
endothelial cells (ECs). However, molecular mechanisms that control the switch of Atox1 from its role as a Cu
chaperone to function as a Cu-dependent transcription factor in inflamed ECs and role of endothelial Atox1 in
atherosclerosis are entirely unknown. SUMOylation plays an important role in regulating transcription factor
localization and DNA binding activity. Our preliminary data show that Atox1 is localized in the nuclei of athero-
prone aorta in which Cu is accumulated. EC-specific Atox1-/- mice show significant reduction of inflammation and
atherosclerosis. Mechanistically, TNFα stimulation in human ECs rapidly induced Atox1 SUMOylation at Lys
(K)3 in ROS-dependent manner, which was required for Cu importer CTR1/Cu-dependent Atox1 nuclear
translocation from cytosol, inflammatory gene expression and EC permeability. Based on our preliminary data,
we hypothesize that SUMOylation of Atox1 via Cys oxidation of deSUMOylation enzyme SENP1 is a key
check point to function as a Cu-dependent transcription factor to promote EC inflammation and barrier
dysfunction, which contributes to pathogenesis of atherosclerosis. Aim 1 will characterize the temporal-
spatial relationships of Atox1 SUMOylation in response to proinflammatory cytokines and examine if ROS-
dependent Atox1 SUMOylation in the cytosol is required for Cu-dependent Atox1 nuclear translocation,
inflammatory responses and EC barrier dysfunction in inflamed ECs. Aim 2 will determine if Cys oxidation (Cys-
OH formation) of deSUMOylating enzyme SENP1 will increase Atox1 SUMOylation in the cytosol, Atox1 nuclear
translocation and transcription factor function, leading to endothelial dysfunction in inflamed ECs. Biotin-labeled
Cys-OH trapping probe will be used. Aim 3 will determine the in vivo significance of endothelial Atox1
SUMOylation in Cu-dependent vascular inflammation and atherosclerosis using EC-Atox1-/- and EC-CTR1-/-
mice, and CRISPR-Cas9-mediated Atox1 K3R knock-in mutant mice. We will use innovative ICP-Mass Spec;
X-ray fluorescence microscopy; Cu fluorescence probe to analyze intracellular Cu in cells and tissues. Our
proposal will provide novel insights into SUMO-Atox1 as a potential therapeutic target for treatment of
inflammation-dependent cardiovascular disease such as atherosclerosis.

Public health relevance
Atherosclerosis is the major cause of mortality in Veteran population. Copper, an essential nutrient, has been shown to have critical roles in vascular inflammation and atherosclerosis with unknown mechanism. The current studies will not only advance the field to understand the molecular mechanism through which copper transporters and copper are involved in the progression of atherosclerotic process, but also provide a basis to discover the novel therapeutic targets and strategies for treatment for atherosclerosis and various vascular diseases.